NEW BIOCOMPATATIBLE TI FOR MAXILLOFACIAL PROSTHESES

DESCRIPTION: The purpose of this research is to develop new titanium alloys for maxillofacial prostheses. Titanium implants have a long history, however there remains considerable potential to optimize their performance for oral and maxillofacial applications. This research will address two significant issues for the development of improved metal implants, namely, the balance of mechanical strength with elasticity, and high-rate osseointegration with long term biocompatiblity. Phase I has demonstrated the feasibility of designing new titanium alloys that retain the desirable strength of commercially available alloys, but provide increased elasticity. Phase II research will pursue an integrated development of new implantable alloys from material synthesis to clinical evaluation. Phase II has for specific aims: 1) develop new high-strength titanium alloys with an increase of elasticity closer to that of bone than present alloys; 2) develop a novel approach to create high Ti content surface textures for better osseointegration; 3) identify promising mechanical properties, corrosion resistant surfaces and in-vitro biocompatibility; and 4) demonstrate desirable osseointegration by in-vivo implant tests. A series of clinical implant tests (rabbit tibia) will be conducted to establish their key benefits as future implantable biomaterial systems based on histological evaluation and pull-out strength measurement. The best alloy/surface system with the highest elasticity will be further evaluated for developing clinically innovative products. PROPOSED COMMERCIAL APPLICATION: Not Available